Michigan Regional Comprehensive Metabolomics Resource Core (MRC2)

DESCRIPTION (provided by applicant): The proposed Michigan Regional Comprehensive Metabolomics Resource Core (MRCMRC or MRC2) is a fully integrated program that will provide researchers nation-wide with the expertise and infrastructure to determine the levels of known and unknown metabolites in cells, tissues and biological fluids. In addition, the MRC will provide opportunities for training in the technology of metabolomic analysis, statistical analysis and bioinformatic evaluation of metabolite data as well as approaches to Incorporation of metabolomics into basic, preclinical, translational and clinical research. Incorporated into this service component will be a robust research component directed towards improving the breadth of metabolite detection, the quality and efficiency of metabolomic analysis and importantly, tools to turn spectral data into knowledge to for the researcher The MRC2 will contain an Administrative Core to oversee and integrate operations; an Analytical Core to help design experiments for directed quantitative measure of metabolites or high-throughput evaluation of large numbers of known and unknown metabolites; a Data and Information Technology Core which will perform primary data processing or re-mining of archival data and will serve as a data repository; a Statistics and Bioinformatics Core which will assist researchers in the statistical evaluation of metabolomic data and integration with other 'omics or phenotypic data; and a Promotion and Outreach Core which will organize and provide seminars, symposia, workshops and web-based videos to increase the lay and research communities knowledge and use of metabolomic data.

Public health relevance
The RCMRC grant is directed towards providing increasing the technology to measure small molecules (metabolites) found in the body. These metabolites are the building blocks of all cells and participate in all body processes. By providing researchers with ways to measure the metabolites accurately from cells and tissues and in the blood, new insights into the ways In which changes in metabolism can contribute to diseases, such as diabetes and caner will be found. With this knowledge, new ways to prevent and treat a variety of diseases may be possible.